CANCER CENTER SUPPORT GRANT--UTAH REGIONAL CANCER CENTER

The faculty and administration of the University of Utah propose to develop a Cancer Research Center, the Utah Regional Cancer Center, firmly based on our strengths in cancer research (molecular, cellular, genetic, epidemiological, pretherapy, and therapy) and certain unusual demographic characteristics of our region and its population. The 7 scientific programs involve over 50 funded investigator-members in 3 schools and colleges of the University and 4 Salt Lake City hospitals. The overall goal of the Cancer Center is to contribute to the national effort to decrease the morbidity and mortality of cancer. The means by which we propose to approach this goal can be stated as our objectives. 1. Facilitate and stimulate interdisciplinary research by providing an academic and administrative link among investigators. 2. Strengthen existing research programs by providing support for core equipment and services used by multiple investigators. 3. Assist in recruitment of new faculty to strengthen our programs by filling current gaps in expertise. 4. Facilitate transfer from the laboratory to the clinic new findings which may reduce the incidence of cancer or improve its treatment. 5. Provide a scientific environment attractive for graduate research education and develop financial support for graduate students, the future leaders in cancer research. 6. Develop improved and augmented facilities for cancer research.